Michigan Predoctoral Training in Genetics

ABSTRACT
This new revised T32 application seeks support for the University of Michigan (UM) Predoctoral Genetics
Training Program (GTP). The GTP mission will be to: (i) train a diverse cohort of outstanding Ph.D. and
M.D./Ph.D. scholars conducting dissertation research with a strong genetic component; (ii) enhance Ph.D.
training by providing an innovative curriculum that familiarizes trainees with all aspects of modern genetic
research; and (iii) implement programs that prepare trainees for exciting, inter-disciplinary career opportunities.
A unique aspect of the redesigned training program is the development of a customized GTP curriculum and the
inclusion of trainees and faculty from six basic science departments that span the UM Medical School (Med) and
College of Literature, Science, and the Arts (LSA). The six participating GTP Departments include: Biological
Chemistry (Med); Ecology & Evolutionary Biology (LSA); Human Genetics (Med); Microbiology & Immunology
(Med); Molecular, Cellular, & Developmental Biology (LSA); and Pharmacology (Med). The GTP will continuously
incorporate improvements to ensure that graduate trainees achieve competency in a broad range of modern
genetic research, including computational genetics and the handling of “big data,” which permeates scientific
research. Other GTP-specific program activities will include: (a) innovative improvements to didactic coursework
and discussion-based learning activities; (b) emphasizing the critical importance of ethical conduct in science
and the necessity of conducting rigorous experiments that yield robust and reproducible results; (c) the
establishment of mechanisms to formally train GTP faculty in mentoring; and (d) the creation of initiatives that
will expose GTP trainees to the many career opportunities available to Ph.D. graduates with training in genetics.
To measure success, we will implement a careful plan to assess genetic competencies continually and
quantitatively throughout the span of graduate training. Finally, the establishment of a new diversity, equity, and
inclusion leadership position will enhance our efforts to actively recruit under-represented minority (URM) faculty
and students from varied scientific disciplines. By soliciting regular trainee and faculty feedback--and through
thoughtful discussions with our outstanding internal and external advisory committees--the GTP leadership will
challenge themselves to identify opportunities for curriculum improvements. The UM Medical School, Rackham
Graduate School, and Department of Human Genetics (the GTP administrative home) will provide additional
funds to support the GTP academic mission. In sum, the GTP will be in a strong position to train the next
generation of genetics professionals to address cutting-edge questions in genetics to benefit society. Based on
the outstanding promise of this program, we respectfully request support for 14 GTP training slots per year.

Public health relevance
NARRATIVE The ever-changing landscape of genetic research requires the training of scientists in state-of-the-art genetics and genomics technologies to answer fundamental mechanistic biological questions that inform us about human biology and disease. The University of Michigan (UM) Predoctoral Genetics Training Program will consist of: (1) a diverse cohort of Ph.D. trainees from six basic science departments spanning the UM Medical School and College of Literature, Sciences, and the Arts campuses; (2) productive faculty with diverse genetics research interests; and (3) a comprehensive curriculum in modern genetics. Here, we present our plan to train the next generation of genetics professionals through: (a) small-group learning experiences; (b) faculty led and peer-to- peer discussions; (c) training-grant specific activities that stress both the ethical conduct of science and critical importance of conducting rigorous and reproducible science; and (d) data-driven evaluation, outcomes, mentoring, and career development programs.